Molecular Basis for Augmentation of Host Response and Un

The goal of the laboratory is to develop new approaches to the study of the genetic basis of cancer and its outcomes, such as infectious complications. The major focus has been on annotating candidate genes, drawn from key pathways in innate immunity and cancer biology, such as telomere stability or nutrient transport (i.e., Vitamin C sodium dependent transport). Specifically, the laboratory has developed approaches to identify and validate common genetic variants, most often, single nucleotide polymorphisms, SNPs, in an effort to define common ancestral haplotypes. In turn, haplotypes as well as SNPs with defined functional consequences (i.e., alteration in function or expression) are applied to studies to determine genetic factors contributing to cancer and its outcomes. We have taken the candidate gene approach, initially with a bias towards selecting known polymorphisms which influence either the level or functional activity of the molecule but recently, adopting an approach that seeks to capture common, ancestral haplotypes.We have invested considerable effort in collecting and analyzing cohorts of subjects with one or more breach in host immune system. Consequently, we have investigated the influence of variant genotypes of molecules of innate immunity on disease susceptibility and outcome in immunocompromised patients. Under the stress of losing a major component of host defense (i.e., neutropenia or an absent respiratory burst- which is characteristic of a rare inherited defect in phagocytic cells, known as chronic granulomatous disease), observed differences in phenotypic expression of disease might be related to polymorphisms in either a regulatory or structural region of primitive immune molecules, such as cytokines, Fc receptors, lectins and interleukins. For instance, we have completely re-sequenced the mannose binding lectin gene, MBL2 and characterized common and uncommon variants. In the process, we have observed that a set of three 'balanced polymorphisms' reside on restricted haplotypes and their distribution across the world (n=30 populations from CEPH Human Diversity Panel) suggest differential patterns of adaptation and selection. Observations in population genetics are critical for understanding the molecular epidemiology of a range of diseases (cancers, infections and autoimmune diseases) associated with MBL2 variants. We have also studied immune variants in other models diseases, such as sickle cell anemia, which also are characterized by a primary defect but clearly modified by secondary genes, such as VCAM1 and the risk for stroke. Because variants are co-inherited as haplotypes from shared ancestors, it is possible to select a subset of markers, namely SNPs, in a region that can capture common genetic variation. Efficiency and power are improved if a set of haplotype tagging SNPs (ht-SNPs) are chosen on the basis of detailed knowledge of the haplotype patterns across a locus of interest. In the process, we have created a database of known genetic single nucleotide polymorphisms (SNPs) in immunologically relevant genes in order to utilize existing SNPs for pathway-based association studies. The long-range goal of genetic association studies is to identify potential genotypic differences that may bear important predictive value for infectious complications of disease (and perhaps other therapy related toxicities). Moreover, we are also heavily invested in studies designed to identify genetic variants in genes of immune function and telomere stability that are associated with susceptibility to pediatric acute lymphoblastic leukemia and lymphomas. The same strategy has also been extended to pilot studies in solid tumors, such as osteogenic sarcoma, colorectal and prostate cancer. The role of inflammation in cancer can be studied in genetic association studies.